COMPARISON OF NOMEGESTROL ACETATE TO MEDROXYPROGESTERONE ACETATE

Comparison of nomegestrol acetate (NA) to medroxyprogesterone acetate (MPA) for coronary reactivity (cardiac catheterization studies) and brachial artery reactivity hyperemia by ultrasound with collaborators at OHSU. FUNDING Theramex